The Role of HNF4a in CKD

PROJECT SUMMARY
Progressive loss of kidney function in chronic kidney disease (CKD) is associated with adverse clinical outcomes
including inflammation, anemia, and bone and mineral disorders that contribute to cardiovascular events and
increased mortality. Limited knowledge of molecular mechanisms that contribute to CKD progression impedes
development of desperately needed therapeutics aimed at reducing morbidity and mortality in patients with CKD.
Expression of hepatocyte nuclear factor 4 alpha (Hnf4α) is dramatically reduced in bone and kidney from patients
and animals with CKD, but the role of HNF4α in CKD progression and CKD-associated outcomes is unknown.
In preliminary data for this project, we establish that deletion of Hnf4α in osteoblasts results in bone loss and
we demonstrate that inflammation is a strong suppressor of Hnf4α expression in bone. We show that HNF4A2
regulates the expression of Pth1r in osteoblasts and that HNF4A deficiency contributes to PTH
hyporesponsiveness in CKD. In additional preliminary data, we show that osteoblast HNF4α provides a major
niche for erythropoiesis by inducing the secretion of EPO from osteoblasts. Consequently, osteoblast deletion of
Hnf4α aggravates iron deficiency anemia. We demonstrate that similar reductions in bone HNF4α in patients
and animals with CKD result in impaired osteogenesis and that overexpression of Hnf4α2 in osteoblasts of mice
with CKD corrects PTH response, skeletal and erythropoietic abnormalities. We further show that Hnf4α is
reduced in the kidney of patients and mice with CKD, and that inhibition or genetic deletion of kidney HNF4α
induces fibrosis and accelerates CKD progression. We also show that hyperphosphatemia and resulting
inflammation suppresses Hnf4α via a STAT3 mediated mechanism. In final preliminary data, we demonstrate
that rescue of HNF4α signaling in the kidney delays CKD progression and propose the reconciling hypothesis
that multiorgan HNF4α deficiency contributes to ROD, anemia and CKD progression.
In Aim 1, we will establish that inflammation suppresses Hnf4α in bone leading to a feed-forward loop, whereby
reduced Hnf4α amplifies the inflammatory signaling, and induces PTH hyporesponsiveness. We will demonstrate
the protective role of HNF4α in bone by genetically inducing and suppressing Hnf4α2 expression in pre-
osteoblasts in mice receiving anabolic PTH challenges and in mice with moderate or advanced CKD. In Aim 2,
we will investigate HNF4α as a regulator of osteoblast-induced bone marrow erythropoiesis via EPO, using
deletion and overexpression of Hnf4α in osteoblasts, in co-cultures with hematopoietic precursors in presence
and absence of EPO, in vivo in two established models of anemia, i.e. iron deficiency anemia and anemia of
inflammation, and in CKD. Finally, in Aim 3 we will investigate the critical role of kidney HNF4a in CKD
progression and STAT3 as an upstream regulator, using mice fed a high phosphate diet and the Col4a3KO mouse
model of CKD. Finally, we will demonstrate the protective role of HNF4A in the kidney by genetically
overexpressing Hnf4α in the proximal tubules in mice with early, moderate and advanced CKD.

Public health relevance
PROJECT NARRATIVE Progressive loss of kidney function, bone fragility and anemia are features of chronic kidney disease (CKD) that contribute to increased mortality. HNF4α is a transcription factor involved in renal tubule repair, osteogenesis and erythropoiesis in normal and iron deficient conditions, and its expression is dramatically and chronically repressed in CKD. This project proposes to test the causative role of sustained HNF4α suppression on the skeleton, bone marrow erythropoiesis, and CKD progression providing new potential therapeutic targets for patients with CKD.